Anatomy Directly from Imagery: General-purpose, Scalable, and Open-source Machine Learning Approaches

Project Summary
The form (or shape) and function relationship of anatomical structures is a central theme in biology where abnor-
mal shape changes are closely tied to pathological functions. Morphometrics has been an indispensable quan-
titative tool in medical and biological sciences to study anatomical forms for more than 100 years. Recently, the
increased availability of high-resolution in-vivo images of anatomy has led to the development of a new generation
of morphometric approaches, called statistical shape modeling (SSM), that take advantage of modern computa-
tional techniques to model anatomical shapes and their variability within populations with unprecedented detail.
SSM stands to revolutionize morphometric analysis, but its widespread adoption is hindered by a number of sig-
niﬁcant challenges, including the complexity of the approaches and their increased computational requirements,
relative to traditional morphometrics. Arguably, however, the most important roadblock to more widespread adop-
tion is the lack of user-friendly and scalable software tools for a variety of anatomical surfaces that can be readily
incorporated into biomedical research labs. The goal of this proposal is thus to address these challenges in the
context of a ﬂexible and general SSM approach termed particle-based shape modeling (PSM), which automat-
ically constructs optimal statistical landmark-based shape models of ensembles of anatomical shapes without
relying on any speciﬁc surface parameterization. The proposed research will provide an automated, general-
purpose, and scalable computational solution for constructing shape models of general anatomy. In Aim 1, we
will build computational and machine learning algorithms to model anatomies with complex surface topologies
(e.g., surface openings and shared boundaries) and highly variable anatomical populations. In Aim 2, we will
introduce an end-to-end machine learning approach to extract statistical shape representation directly from im-
ages, requiring no parameter tuning, image pre-processing, or user assistance. In Aim 3, we will provide intuitive
graphical user interfaces and visualization tools to incorporate user-deﬁned modeling preferences and promote
the visual interpretation of shape models. We will also make use of recent advances in cloud computing to enable
researchers with limited computational resources and/or large cohorts to build and execute custom SSM work-
ﬂows using remote scalable computational resources. Algorithmic developments will be thoroughly evaluated and
validated using existing, fully funded, large-scale, and constantly growing databases of CT and MRI images lo-
cated on-site. Furthermore, we will develop and disseminate standard workﬂows and domain-speciﬁc use cases
for complex anatomies to promote reproducibility. Efforts to develop the proposed technology are aligned with
the mission of the National Institute of General Medical Sciences (NIGMS), and its third strategic goal: to bridge
biology and quantitative science for better global health through supporting the development of and access to
computational research tools for biomedical research. Our long-term goal is to increase the clinical utility and
widespread adoption of SSM, and the proposed research will establish the groundwork for achieving this goal.

Public health relevance
Project Narrative This project will develop general-purpose, scalable, and open-source statistical shape modeling (SSM) tools, which will present unique capabilities for automated anatomy modeling with less user input. The proposed tech- nology will introduce a number of signiﬁcant improvements to current SSM approaches and tools, including the support for challenging modeling problems, inferring shapes directly from images (and hence bypassing the seg- mentation step), parallel optimizations for speed, and new user interfaces that will be much easier and scalable than the current tools. The proposed technology will constitute an indispensable resource for the biomedical and clinical communities that will enable new avenues for biomedical research and clinical investigations, provide new ways to answer biologically related questions, allow new types of questions to be asked, and open the door for the integration of SSM with clinical care.